Early Psychosis Intervention Network (EPINET): Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
This application outlines and describes the proposal by the Westat team to serve as the National Institute of
Mental Health (NIMH) Early Psychosis Intervention Network (EPINET) National Data Coordinating Center
(ENDCC). The ENDCC will, in collaboration with up to five regional scientific hubs and a minimum of 20
Coordinated Specialty Care (CSC) sites funded under the companion NIMH EPINET RFA, facilitate and
accelerate practice-based research in clinics providing evidence-based, coordinated care to persons in the
early stages of psychotic illness. Evidence establishes that early intervention, specifically CSC, can improve
symptoms and functioning. The Westat team envisions the ENDCC creating a scalable, flexible, and
sustainable national platform that can accommodate a larger network of CSC programs. NIMH will, through the
ENDCC, create the infrastructure essential to facilitate collaboration, share data elements, exchange
innovative clinical practices, and provide analytic support and dissemination activities necessary to improve
identification, diagnosis, assessment, effective interventions, and outcomes for early psychosis. The specific
aims for the ENDCC are to: (1) serve as the central coordinating entity for regional scientific hubs and facilitate
the sharing of data collection strategies, early psychosis data, analytic methods, and clinical expertise; (2)
curate and harmonize key assessment measures, clinical strategies, and data elements across regional
scientific hubs; (3) implement a health informatics approach within and across regional hubs; (4) facilitate
practice-based research through the development of a research dissemination infrastructure; and (5)
disseminate CSC resources to the broader scientific, provider, and patient community, including the
development of a public ENDCC website. The Westat ENDCC team includes highly experienced staff in health
informatics, complex statistical analysis, data and workflow management, dissemination, service delivery and
policy, and the conduct and coordination of the types of large, complex, and multi-layered projects represented
by EPINET. The ENDCC will be guided by a Steering Committee composed of representatives from the
regional scientific hubs, and a Research Advisory Group consisting of experts in FEP, child psychiatry, CSC
implementation, health informatics, fidelity assessment, and research ethics who are not investigators with the
regional hubs.

Public health relevance
PROJECT NARRATIVE This project will establish the National Institute of Mental Health (NIMH) Early Psychosis Intervention Network (EPINET) National Data Coordinating Center (ENDCC). The ENDCC will collaborate with up to five regional scientific hubs and a minimum of 20 Coordinated Specialty Care (CSC) sites funded under the companion NIMH EPINET RFA. The project will create the infrastructure essential to facilitate collaboration, share data elements, exchange innovative clinical practices, and provide analytic support and dissemination activities necessary to improve identification, diagnosis, assessment, effective interventions, and outcomes for early psychosis.